Novel bioreducible polymer-based delivery platform for intravitreal gene transfer to retina

PROJECT SUMMARY
Our primary goal in this proposal is to develop a polymer-based synthetic gene delivery platform for gene therapy
of acquired and/or inherited retinal and optic nerve disorders. Viral vectors, particularly adeno-associated virus
(AAV), have been the gene delivery vector of choice to date but several inherent shortcomings necessitate an
alternative that can accommodate the ever-increasingly need for novel gene therapy products. These include
limited packaging capacity, vector-specific immune responses, and extremely high cost. In addition, subretinal
injection, despite being widely practiced and affording direct access to the outer retinal layer, poses several
drawbacks such as photoreceptor trauma and limited topographic therapeutic coverage. To this end, we propose
to develop and evaluate novel environmentally-sensitive polymer-based gene delivery nanoparticles (NPs) for
intravitreal gene delivery to the retina for broad retinal gene therapy applications while avoiding the above-
mentioned limitations. Specifically, our platform will be designed to overcome key extracellular barriers, including
the vitreous gel and inner limiting membrane, to enable widespread retinal gene transfer, and to promote
endosomal escape and intracellular release of therapeutic nucleic acid payloads for enhanced transfection of
retinal cells. Importantly, non-immunogenic nature of our platform will allow multiple administrations to amplify
the level of transgene expression, potentially matching or surpassing the efficacy achievable by clinically
validated viral vectors. Of note, although non-viral gene delivery systems do not readily exhibit a specific cell
tropism, cell-specific therapeutic transgene expression can be achieved with the use of cell-specific promoters if
desired. Synthetic gene delivery systems that provide extensive and safe transgene expression in retina can be
of broad clinical utility.

Public health relevance
PROJECT NARRATIVE Retinal gene therapy has emerged as a breakthrough therapy for treating patients with vision impairment or irreversible vision loss. However, current gene delivery approaches that involve highly invasive procedure of injecting virus-based products into the back of the eye often associate with limited therapeutic coverage, safety concerns and enormous economic burden. Here, we propose to develop a highly cost-effective gene delivery strategy that can potentially promote comprehensive treatments of numerous eye diseases while minimizing safety concerns.